Multifile probabilistic record linkage for drug overdose surveillance and public health action

Record linkage refers to the process of integrating data by identifying unique individuals within and across data sources. In administrative databases, it is common to have a limited amount of the individuals' partial identifiers, such as names or dates of birth, which together with typographical errors and missing data, makes the record linkage task difficult and prone to errors. Probabilistic record linkage approaches have been shown to have superior performance when compared with ruled-based deterministic techniques, as probabilistic approaches adapt better to different and increased levels of error in the datafiles. Existing probabilistic approaches are nevertheless subject to different limitations. In practice, it is common to encounter data integration scenarios where multiple data sources need to be simultaneously merged and deduplicated using imperfect information such as names, dates or addresses. These scenarios go beyond the specifications for which commonly used record linkage and deduplication methodologies have been developed. We therefore propose to extend the currently-available best-performing record linkage methodologies to simultaneously integrate multiple datafiles and detect duplicated records within them. We will develop this methodology, with an associated software and graphical user interface, in partnership with Public Health – Seattle & King County to ensure that these are responsive to real world needs and challenges. We will also conduct a pilot study implementing the techniques on King County administrative data systems used for overdose surveillance and evaluation of overdose prevention programs.

Public health relevance
Government agencies manage multiple independent databases that shed light on different aspects of drug related harms in their jurisdictions, but these databases are rarely integrated, limiting their potential to inform overdose prevention strategies and programs. We will extend the currently-available best-performing record linkage methodologies to simultaneously integrate multiple datafiles and detect duplicated records within them. By augmenting governmental capacity to apply these “big data” tools to their administrative data systems, we will enhance public health practitioners' ability to identify promising overdose prevention strategies, make informed decisions regarding prioritization and targeting, and evaluate the impact of overdose prevention programs.